Molecular Mechanisms of Bacterial Stress Response Relevant to Host-Microbe Interactions

PROJECT SUMMARY/ABSTRACT
The interface between bacteria and the immune system is absolutely fundamental to human health. The broad,
long-term objective of this research project is to understand this interface.
The innate immune system controls bacterial colonization of epithelial surfaces with a variety of heme peroxidase
enzymes that generate powerful antimicrobial oxidants, including hypochlorous acid (HOCI; the active ingredient
in household bleach), hypobromous acid, and hypothiocyanite. Different kinds of bacteria are able to mount a
variety of defenses against these toxic chemicals, which determines their ability to survive on host epithelial
surfaces. For pathogenic bacteria, these defensive pathways are important for their ability to cause disease,
while for health-promoting probiotics and commensal members of the microbiome, they are determinants of how
well those species are able to colonize their hosts and survive during periods of inflammation.
In response to HOCI, Escherichia coli (a proinflammatory member of the gut microbiota) and other bacteria
synthesize large amounts of inorganic polyphosphate (polyP), a universally conserved biopolymer of phosphate
up to 1000 units long. PolyP contributes to bacterial survival by, among other functions, stabilizing damaged
proteins and regulating protease activity and chromosome replication. However, very little is known about how
the production of this protective compound is regulated in response either to HOCI or to other stress conditions.
The most highly upregulated genes in HOCl-exposed E. coli are those belonging to the re/ABC operon, controlled
by the HOCl-sensing transcription factor RclR. RclA has copper (11) reductase activity, protects E. coli against
the combination of HOCI and intracellular copper toxicity, and is conserved among a very wide range of hostcolonizing
bacteria, including both health- and disease-associated species. The precise mechanism by which
RclA protects bacteria against these stresses remains unclear, however, as do the functions of the RclB and
RclC proteins, which are conserved only in proinflammatory enterobacteria.
Therefore, the key gaps in understanding addressed in this research proposal are the following:
1. How do bacteria regulate the synthesis of inorganic polyphosphate?
2. How do the RclABCR proteins protect host-associated bacteria against oxidative stress?
3. How do these pathways affect host-microbe interactions?
We will address these questions using a validated, collaborative research strategy that uses genetic and transcriptomic
analysis of specific stress-sensing regulators to identify relevant genes and pathways in host-associated
bacteria, followed by combined genetic, bioinformatic, and biochemical approaches to establish a mechanistic
understanding of the relevant microbial physiology.

Public health relevance
PROJECT NARRATIVE Bacteria have major impacts on human wellness, both as the causes of acute infections and as members of the health-promoting microbiome. The research described in this proposal is aimed at understanding how bacteria sense and respond to antimicrobial oxidants produced by innate immune cells at the interface between microbes and host organisms. We expect the results of these studies to contribute to fundamental knowledge about how both health- and disease-associated bacteria interact with the immune system, which, in the long term, will facilitate the development of new strategies to manipulate those interactions to promote human health.